Role of Data Streams In Informing Infection Dynamics in Africa- INFORM Africa

PROJECT SUMMARY/ABSTRACT
A key problem in Africa is the paucity of population-scale epidemiologic data sources and analytical capacity to
rapidly identify and understand infectious disease pandemics. Yet, in the context of fragile health systems and
limited resources, the need for population-scale epidemiologic data is even more urgent to provide information
on transmission dynamics and inform interventions. The overall goal of the ‘Role of Data streams In
Informing infection dynamics in Africa (INFORM Africa) Hub’ is to effectively use big data to address
pressing public health needs of SARS CoV-2 and HIV pandemics with the overall goal of developing
population-scale data streams as a cornerstone of future pandemic preparedness. INFORM Africa
proposes to use existing data from Nigeria and South Africa, the two most impacted countries in Africa
accounting for 41% of the continent’s SARS-CoV-2 infection and about 40% of its HIV burden. The Hub is led
by two well-established and successful non-governmental organizations: Institute of Human Virology Nigeria
(IHVN) and the and the Centre for the AIDS Programme Of Research In South Africa (CAPRISA) with strong
links with Universities and their respective government agencies, also engaged. INFORM Africa also partners
with a private partner from the industry – Akros Zambia. INFORM Africa has assembled experienced
researchers with complimentary expertise in big data analytics, quantum information processing, spatial
statistics and analysis, genetics, computational biology, agent-based and data driven modelling, clinical
infectious diseases, infectious disease epidemiology, molecular virology, and geospatial analytics to address
the goal of this submission through four Specific Aims. AIM 1 establishes data streams from public and private
sectors in order to understand the multilayer interactions that may explain the dynamics and impact of COVID-
19 pandemic, through three proposed Research Projects and two proposed Cores, supplemented by the pilot
projects. AIM 2 develops geospatial tools for use by country leadership and governments in pandemic
surveillance and response to improve preparedness. AIM 3 expands data science research opportunities and
capacity through the engagement with the broader DS-I Africa consortium and through several proposed pilot
projects in data science. AIM 4 maintains a sustained engagement with the policy makers and governments in
order to promote further open access to high quality data and the redistribution and uptake of any product/tool
developed by the INFORM Africa. The DMAC & NGS Core is the lynchpin of INFORM Africa, assembling and
managing the Research Hub’s data and providing seamless access to a set of tools and workflows that link the
Hub to the broader DS-I Africa Open Science Data Platform and coordinating center. The Administrative Core
harmonizes and streamlines administrative, financial, and communication processes for INFORM Africa, and
coordinates the selection of pilot projects consistent with INFORM Africa’s aims, and in compliance with DS-I
Africa requirements. Project and Core leads make up the MPD/PI leadership and the Steering Committee of
the INFORM Africa supported by a Scientific Advisory Board.

Public health relevance
PROJECT NARRATIVE The goal of our Research Hub, which is called ‘INFORM Africa’ (Role of Data Streams In Informing Infection Dynamics in Africa), is to understand how we can use big data from the different sources on infections or disease in Africa, starting with Nigeria and South Africa, in order to explain better what we do daily as a community that puts us at risk of infection and the spread of the virus like with COVID-19 and HIV. If we know this, we may be able to prevent future epidemics and pandemics from happening or at least be better prepared for them so that the spread and deaths is reduced. Making all data that still protects the privacy of those that provided it easily available for all scientists to work together on the data will help us know what to do much faster.